Cu importer CTR1 Cys189 oxidation in atherosclerosis

The aim of this grant is to elucidate the novel role of endothelial Cu importer CTR1 Cys189 oxidation to
protect against Cu-dependent senescence and cuproptosis involved in inflammatory vascular disease.
Oxidative stress, inflammation, mitochondrial (mito) ROS/dysfunction in endothelial cells (ECs) contribute to
atherosclerosis, which is the major cause of mortality in the Veteran population. However, current anti-
inflammatory and antioxidants therapy have mixed results. Evidence suggests that senescent cells provide a
chronic source of pro-inflammatory cytokines, and thus become potential therapeutic targets for atherosclerosis.
Copper (Cu), an essential micronutrient, is increased in human atherosclerotic plaques, while Cu promotes, and
Cu chelators inhibit atherosclerosis in mice via unknown mechanisms. Excess Cu and mitoROS are shown to
promote senescence. Since excess Cu is toxic, the bioavailability of intracellular Cu ([Cu]i) is tightly controlled
by the Cu importer CTR1 that promotes Cu entry to provide Cu not only to the cytosolic Cu chaperone/nuclear
Cu-dependent transcription factor Atox1 to promote inflammation, but also to the mito matrix to maintain mito
function. We reported that growth factor VEGF-induced H2O2 stimulates rapid oxidation of CTR1 at Cys189,
which promotes VEGFR2 signaling and angiogenesis in ECs. In contrast, the highly conserved CTR1-HCH190
triad in C-terminal is known to be involved in Cu-induced CTR1 regulatory endocytosis which prevents excess
Cu entry-driven Cu toxicity; however, the role of endothelial CTR1-Cys189 in Cu- and ROS-dependent
senescence and atherosclerosis is entirely unknown. In addition to senescence, recent study reported that
excess Cu induces a new type of programmed cell death, termed “cuproptosis”, characterized by decrease in
lipoylated TCA cycle proteins and Fe-S cluster proteins, resulting in mito dysfunction and cell death. Role of
cuproptosis in atherosclerosis and its relation to endothelial CTR1-Cys189 remain elusive. Our preliminary data
suggest that inducible EC-specific mCtr1-/-/ApoE-/- with high fat diet (HFD) mice aorta exhibited reduced
atherosclerosis vs. atherosclerotic ApoE-/-/HFD mice aorta which showed Ctr1-CysOH formation vs. control
ApoE-/-/chow diet mice. Unexpectedly, inhibiting Ctr1 Cys oxidation using our CRISPR/Cas9-generated “redox-
dead and internalization defective” CTR1-Cys189Ala knock-in mutant (mCtr1-C/A)/ApoE-/-/HFD mice showed
accelerated atherosclerosis vs. ApoE-/-/HFD mice, which was due to increasing mito[Cu]i and inhibited by Cu
chelator TTM. These in vivo data were recapitulated by using human ECs stimulated with proatherogenic
cytokine TNF. With other preliminary data, we will test the novel hypothesis that endothelial CTR1-Cys189
oxidation limits excess Cu entry to protect against pro-atherogenic phenotype of CTR1/Cu. Preventing
CTR1-Cys189-mediated internalization increases mitoCu following CTR1 binding to mitoCu transporter,
leading to mitoROS-senescence/inflammation axis as well as mito dysfunction/cuproptosis axis, which
accelerates atherosclerosis. Aim 1 will establish the role of CTR1-Cys189 oxidation in limiting excess Cu-
induced senescence and cuproptosis in inflamed ECs stimulated with TNF. Aim 2 will examine if preventing
CTR1-Cys189 oxidation-mediated internalization increases mitoCu following CTR1 binding to mitoCu transporter
in ECs stimulated with TNF. Aim 3 will determine whether endothelial CTR1-Cys189 oxidation protects against
atherosclerosis by limiting excess Cu-induced senescence and cuptoptosis in vivo. We will use inducible EC-
Ctr1-/- or -SLC25a3-/- mice or innovative CRISPR/Cas9-generated mCtr1-C/A mice with HFD or partial carotic
ligation atherosclerosis models. We will also use compartment-specific redox-sensitive biosensors; biotin-
labeled CysOH trapping probe; scRNAseq and scATACseq; newly developed, mito-targeted Cu-depleting
nanoparticle (mitoCDN); highly innovative ICP-Mass Spec, X-ray fluorescence microscopy and mito-targeted
Cu fluorescence probes to measure Cu levels. Our proposal will provide new insights into mitoCu or endothelial
CTR1 Cys189 oxidation as a potential therapeutic target for Cu-dependent inflammatory vascular disease.

Public health relevance
Oxidative stress, inflammation, mitochondrial dysfunction and senescence in endothelial cells contribute to atherosclerosis, which is the major cause of mortality in the Veteran population. Recently, excess copper (Cu) in mitochondria is shown to induce a new type of programmed cell death. We will demonstrate that Cysteine oxidation of endothelial Cu uptake transporter CTR1 plays an important role in regulating Cu levels, inflammation, mitochondrial dysfunction and programmed cell death in atherosclerotic lesions and potential therapeutic target for the treatment of vascular inflammatory disease.